Nurse-Led Interventions in Pediatric Critical Care: Training in Pediatric Sleep Health, Delirium, and Multi-Site Research

PROJECT SUMMARY/ABSTRACT
Delirium is a serious, potentially iatrogenic, complication of pediatric intensive care unit (PICU) care and is
associated with poor clinical outcomes. Poor sleep quality during critical illness is a proposed cause of delirium.
Upon admission, children experience a chaotic PICU environment that disrupts sleep/wake patterns, including
lack of day/night light and sound cycling and frequent examinations and procedures. This PICU care model
is neither child- nor family-centered and likely disrupts sleep health. Good sleep health requires regularity in
sleep/wake patterns with appropriate sleep timing, high sleep efficiency, and adequate sleep duration to
promote physical and mental well-being. The primary purpose of this research training plan (R2-PD) is to
use existing data to explore associations among sleep health (i.e., timing, efficiency, duration, regularity), sleep
biology (i.e., melatonin dysregulation), and pediatric delirium. The data are from RESTORE Resilience (R2;
R21HD093369), a 2-center, prospective cohort trial of a nurse-driven care bundle designed to maintain
sleep/wake rhythms in 54 children (6 m.o.-17 y.o.) with acute respiratory failure on mechanical ventilation.
Specific aims of R2-PD include: (1) Examine relationship between sleep health (i.e., daytime activity ratio
estimate [timing], sleep episode duration, total sleep time [duration], sleep efficiency) and pediatric delirium
(i.e., incidence, duration). (2) Determine association between implementation of a nurse-driven care bundle
that promotes sleep/wake cycle regularity and pediatric delirium (i.e., incidence, duration). (Exploratory)
Explore differences in salivary melatonin levels (i.e., mesor, amplitude, acrophase) over time (i.e., study days 2
and 5) in critically ill children with and without delirium. This study will be among the first to explore links
among sleep disruption, melatonin levels, and delirium in a sizeable critically ill pediatric cohort followed for
9.8 (SD=7.7) days. Combined with in-depth training in multi-site clinical trial conduct with Dr. Martha Curley
(Sponsor) and pediatric sleep health with Dr. Monica Ordway (Mentor), the R2-PD analysis will provide
preliminary data for future, large-scale nurse-led clinical trials of individualized sleep-promoting interventions
to prevent pediatric delirium. Training goals for the 18-month post-doctoral period at the University of
Pennsylvania include: (1) Expand knowledge of pediatric sleep health as a multi-dimensional construct and
understand how sleep health relates to pediatric critical care and delirium. (2) Receive advanced training in
multi-site clinical trial conduct and data coordination. (3) Advance scientific understanding of pediatric critical
illness through research dissemination. (4) Develop professionally in preparation for career as an independent
pediatric critical care researcher. This application aligns with NINR interest in training nurse scientists
in intervention research with PICU nursing practice implications (NOT-NR-21-001). The long-term goal
of this research program is to improve clinical outcomes and quality of life in survivors of pediatric critical
illness with interventions that incorporate individual family care patterns to optimize healing in the PICU.

Public health relevance
PROJECT NARRATIVE Delirium in the pediatric intensive care unit is associated with increased hospital length of stay, cost of care, and child mortality. The purpose of this training application is to use existing data to examine the potential relationship between sleep disruption and delirium in critically ill children. Together with training in the conduct of multi-site clinical trials, the results of this research will be used to design future nurse-led interventions that promote sleep and prevent delirium in the pediatric intensive care unit.